The Proteomic Signature of Dual Decline in Gait and Cognition

Project Summary. It is well-accepted that altered gait can precede the clinical diagnosis of cognitive
impairment and is a significant risk factor for cognitive decline. Older adults with combined altered gait and
cognitive changes (dual-decline) are at greater risk of developing dementia than older adults with changes in
only gait or cognition and stable function. Dual-decline incidence is high, estimated to have a pooled
prevalence of 10.2% of older adults, and is additionally impactful because altered gait in those with Alzheimer’s
disease (AD) and related dementias (ADRD), and leads to more frequent and injurious falls and greater
healthcare costs. Unfortunately, an important knowledge gap persists regarding the pathophysiological
changes that link declines in gait with dementia. There is a critical need to identify underlying
pathophysiological changes to improve early detection and inform interventions for the dual-decline population.
The overall objective of this application is to use a systems biology approach of proteomics to understand the
pathophysiological changes associated with dual decline. Recent advances in proteomics technology have
contributed to many breakthroughs in disease-related biomarker discovery and in understanding the pathways
contributing to increased disease risk. Plasma proteomics has identified both AD-related proteins and altered
gait-related proteins in cognitively unimpaired cohorts with potentially overlapping pathways. The proteome of
dual decline, however, has not yet been determined. We will leverage a deeply phenotyped cohort, the
Vanderbilt Memory and Aging Project (VMAP), with plasma proteomics (Olink Explorer 3072) at study entry
and repeat measures of clinical gait speed, actigraphy, and neuropsychological assessments. This study
proposes both cross-sectional (Aim 1) and longitudinal methods (Aim 2) to examine the unique proteome of
dual decline. In each aim, we will also investigate gait changes derived from clinically measured gait speed
(clinical gait) and gait characteristics extracted from actigraphy during everyday living (free-living gait). Free-
living gait differs from clinically measured gait and may provide additional novel insights into the etiology of
dual decline. Analyses will then be replicated in the Baltimore Longitudinal Study on Aging and compared with
dual decline proteins and pathways identified in the VMAP cohort. Discovery of a unique proteome may identify
predictors and treatment targets, potentially transforming early detection and intervention strategies for aging
adults with an elevated risk of functional and cognitive decline. This K76 research proposal and parallel training
plan will expand upon my expertise in motor control (gait) and signal processing (free-living gait) with
neuropsychological assessment, advanced statistical methods, and aging systems biology (proteomics).
Accomplishing the proposed training and research project will uniquely position me as a leader and expert in
the intersection of physical function and systems biology, enabling me to lead the way in developing precision
detection and treatment strategies in ADRD.

Public health relevance
Project Narrative. Older adults with combined altered gait and cognitive changes (dual-decline) are at greater risk of developing dementia than older adults with changes in only gait or cognition and stable function, however, the pathophysiological changes that link declines in gait with dementia are unknown. The objective of this application is to use a systems biology approach of proteomics to understand the pathophysiological changes associated with cross-sectional and longitudinal trajectories of dual decline. Discovery of a unique proteome may identify predictors and treatment targets, potentially transforming early detection and intervention strategies for aging adults with an elevated risk of functional and cognitive decline.